Miniscope in vivo imaging of cumulative traumatic brain injury

Project Summary/Abstract
In the United States, millions of people sustain a traumatic brain injury (TBI) each year carrying individual,
healthcare, and societal costs greater than $45 billion annually. Mild TBI (mTBI) accounts for more than 75% of
all TBIs, with many individuals sustaining more than one. mTBI patients report post-concussion syndrome (PCS)
symptoms that include sleep disorders (insomnia, daytime sleepiness), somatic symptoms (dizziness, headache,
blurred vision), cognitive complaints (memory, executive function), and emotional problems (anxiety, depression,
irritability, disinhibition). For many, PCS is transient, and still 10-25% report persistent PCS symptoms. The
enigmatic PCS symptom presentation and persistence after mTBI urges investigation into dynamic responses
in the brain that tie acute neurophysiology to behavioral function. The investigative team has refined in vivo
imaging methods of miniaturized microscopes (miniscopes) to evaluate cerebral blood flow (CBF) and blood
brain barrier (BBB) permeability in the unrestrained, behaving mouse. New preliminary data leverage the
miniscope headcap to induce impact acceleration (weight drop) closed head injury. The data driving this proposal
show immediate accumulation of fluorescent dextrans in the parenchyma within the field of view. The strength
of this approach eliminates anesthesia during long-duration imaging, permits naturalistic behavior without head
restraint, and locks into a baseplate for repeated imaging of single channel, wide-field, fluorescence. For the first
time, the cumulative effects of TBI on neurophysiology (CBF, BBB permeability, sleep) can be regressed toward
neurobehavioral impairments. The present proposal tests the hypothesis that the cumulative effects of
mTBI on CBF and BBB permeability promote post-traumatic sleep and predict neurological impairments.
Male and female mice are prepared for miniscope imaging through a cranial window and attached baseplate.
The baseplate headcap substitutes for a helmet in closed-head impact acceleration TBI. With a 15 sec transition,
miniscopes visualize CBF and BBB permeability with intraperitoneal dextrans (40-2000 kDa) in vasculature and
parenchyma, respectively. The cumulative effects of mTBI are assessed with impacts delivered twice daily, daily,
or every other day for a week. Aim 1 monitors the cumulative effects of mTBI with varying temporal spacing on
CBF concurrent with post-traumatic sleep and subacute behavioral performance. Aim 2 quantifies the extent of
dextran extravasation with post-traumatic sleep and subacute neurological performance. Neurological outcomes
include anxiety (open field), spatial memory (novel object location), and somatosensory pain (mechanical
hyperalgesia). Twice daily injuries likely show temporal summation of CBF, BBB permeability, and sleep effects,
which are recovered with longer recovery times between injuries. The integration of miniscope imaging and
closed head injury can propel future studies on physiological perturbations and clinical management of TBI.

Public health relevance
Project Narrative The manner in which the brain responds to cumulative traumatic brain injuries (TBIs) and leads to neurological dysfunction is unknown. Our approach permits inter-injury in vivo microscopy to observe injury- induced change in blood flow and blood-brain barrier permeability, while recording post-traumatic sleep, as predictors of subacute neurological function. New insights to cumulative pathophysiology after TBI can inform clinical management and studies to reduce damage and accelerate recovery.